Solvation directed drug design: from molecular physics to lead optimization

Project Summary
This project aims to develop new methods and computational tools that will speed structure-based drug-
discovery and apply these methods to identify new lead drug candidates for the mu-opioid receptor and SARS-
CoV-2 main proteases. This will be accomplished by providing a detailed analysis of hydration structure and
thermodynamics in targeted protein binding pockets then incorporating this information into docking and
water-based pharmacophore virtual screens. Key aims are to develop analysis tools that characterize and map
out solvation on the surfaces of drug target then utilize these solvation structural and thermodynamic maps to
improve computational methods of binding pocket druggability, virtual screening of purchasable compound
databases, and rational lead modification. Preliminary results for a new method of virtual screening that
combines constructing pharmacophores based on water-protein interactions with ROCS fast shape and pattern
matching show the method is greater than 3 orders of magnitude faster than computational docking.

Public health relevance
Project Narrative Most medications are molecules that work by binding tightly to a specific pocket in the surface of a protein involved in a disease process, and thus blocking the protein’s disease-related function. This project aims to develop advanced computational methods and software that will speed the discovery of new medications by helping scientists identify druggable pockets on protein surfaces then design or discover molecules that will bind tightly to a targeted protein.